Adaptable Community-Engaged Intervention for Violence Prevention: Michigan Model

Adaptable Community-Engaged Intervention for Violence Prevention: Michigan Model
Abstract
Firearm possession and carriage are critical risks for firearm injury and mortality. Asian Americans (As-As) are
one of the fastest growing populations in the U.S. A recent study36 conducted by the project team showed that
racism and its link to increased firearm ownership and carrying during the pandemic put Asian Americans at a
higher risk of firearm injury. Our long-term goal is to take action upstream to prevent injury and mortality by
intervening with modifiable factors that place individuals at greater risk of involvement in firearm-related
violence (FRV) in this vulnerable population. In this two-phase research project, the goal of the planning (UG3)
phase is to employ a mixed methods participatory action approach including photovoice and Geographic
Information System (GIS) to investigate multi-level risks and protective factors against FRV, identify
community-level resources and understand the intersectionality and contexts between these factors and
firearm outcomes. For the implementation (UH3) phase, the study team plans to use the findings generated in
UG3 phase as an analytical tool to reveal salient multi-level factors related to FRV outcomes and develop,
implement and evaluate proposed violence prevention intervention strategies that prioritize health equity and
advance racial justice. Specifically, the study team will 1) Conduct a cluster randomized trial to examine effects
of proposed intervention on individual- and community level outcomes related to firearms violence, and 2)
Perform in-depth case studies with community implementation sites to understand barriers and facilitators for
future adoption and sustainability. Throughout the project period, the study will collaborate in all phases and
actively participate in CLIF-VP Research Network activities, including participation in workgroups and regular
meetings with the Steering Committee and closely working with the Coordinating Center for data support and
technical assistance in measurement, data handling, management, harmonization, sharing/archiving) and
consultation for public engagement and scientific dissemination products. The expected outcomes of the
project will provide a solid basis for development and testing of an evidence-based intervention that prevents
firearm violence among Asian Americans. The proposed Community Health Worker (CHW) violence
prevention, if tested and shown effective, has a potential for scalable adaptations to other settings.

Public health relevance
Narrative The proposed research responds to the priorities of Research on Community Level Interventions for Firearm and Related Violence, Injury and Mortality Prevention (CLIF-VP)(UG3/UH3) through a community-engaged approach to obtain a comprehensive understanding of multi-domain risk and protective factors of firearm- related violence and develop, implement and evaluate culturally-sensitive community-level violence prevention. The expected outcomes of the project will provide a solid basis for establish the evidence for effective strategies to prevent firearm violence and; ultimately, minimize the public health burden of firearm injury and mortality among minority and underserved populations.